Two-way Texting (2wT) to Improve Patient Retention While Reducing the Healthcare Workload in High-Burden Public HIV Clinics in Malawi

In sub-Saharan Africa (SSA), retention of HIV-infection people in antiretroviral therapy (ART) is an increasing
challenge. With only 67% retained on ART in SSA, over 7.5 million people are out of care, threatening both
individual health and HIV epidemic control. With significant healthcare system constraints and formidable
healthcare worker (HCW) shortages, ART services in SSA struggle to meet ambitious global targets of 90%
retained in care. In research settings, text-based mHealth innovations show promise to increase ART retention
and, therefore, reduce viral load (VL). However, few mHealth innovations have been tested or proven effective
in real-world settings with severe human and financial resource constraints. mHealth innovations that
successfully retain more patients on ART, at lower cost, within large-volume public ART clinics in SSA are
urgently needed. Lighthouse Trust (LT), the largest public provider of ART in Malawi, operates two large clinics
in Lilongwe with the Malawi Ministry of Health (MoH), Lighthouse Clinic (LH) and Martin Preuss Center (MPC),
with a combined 35,000 ART patients. 12-month retention at Lighthouse is 67%, below the 90% global target for
epidemic control. Both clinics employ a real-time electronic medical records system (EMRS) and implement a
resource-intensive patient retention program, Back to Care (B2C). B2C aims to trace patients who miss ART
visits by >14 days. MPC has over 7800 monthly ART visits, and more than 10% of clients are B2C-eligible. B2C
demand, coupled with HCW constraints, results in tracing of only 33% of target clients. Lack of, or delayed,
tracing reduces ART retention. Moreover, over 50% of traced B2C clients are found on ART, 60% of whom had
transferred, demonstrating significant unnecessary tracing. Poor data quality reduces B2C effectiveness.
Therefore, the University of Washington’s International Training and Education Center for Health (I-TECH) and
LT, with support from MoH and Medic Mobile, seek to implement an innovative, proactive, patient retention
system using two-way texting (2wT) between new ART patients and staff. 2wT will resolve potential retention
issues before they occur and improve data quality (e.g. identifying transfers), reducing B2C workload. Using a
quasi-experimental, pre-post design, this R21 (Aim 1) will test a hybrid 2wT intervention to provide adherence
support for, and visit-focused communication with, new ART initiates at MPC clinic, comparing retention (ART
outcomes, visit adherence, VL) and B2C referrals among two groups of new MPC ART clients: 2wT-supported
(prospective intervention) and matched pre-2wT (retrospective comparison). After demonstrating improved
retention at lower cost (Aim 2) using research teams (R21: years 1-2), 2wT integration into the EMRS (R33:
years 3-5) will automate enrollment and management of 2WT for new clients in both LH and MPC using routine
HCWs (Aim 3), assessing the transition of research to practice. The proposed mHealth study will significantly
increase ART retention in public ART clinics using routine HCWs, reducing workload and costs. This innovative
approach in high-volume, public settings in Malawi sets the stage for national or regional scale-up.

Public health relevance
Project narrative In sub-Saharan Africa (SSA), where need and resource constraint are highest, sub-optimal antiretroviral treatment (ART) retention threatens to derail global HIV epidemic control efforts. Through a quasi-experimental, pre-post designed test of an mHealth innovation and subsequent scale-up in two, high-volume, public ART clinics with over 35,000 ART clients in Malawi, we aim to demonstrate that interactive, two-way texting (2WT) can increase ART retention in a routine setting while providing distinct advantages in terms of data quality, costs, and reduced healthcare worker burden over routine retention efforts. User-centered assessment of successful 2WT integration into the existing electronic medical records system facilitates transfer from research to routine practice, enabling scale-up of this mHealth intervention to improve ART retention across Malawi and SSA.